T cell trafficking to the small intestine in Cryptosporidium infection

Project Summary
The apicomplexan parasite Cryptosporidium is a leading cause of diarrhea and death due in
immunocompromised individuals and malnourished children globally. Control of
Cryptosporidium requires T cells to migrate to the small intestine. However, there are significant
gaps in our understanding of the regulation of T cell responses against the parasite. This is in
large part due to difficulties analyzing T cell populations in the gut, which is home to many
activated cells at baseline. The Hunter and Striepen laboratories have developed a novel
system for studying T cell responses by engineering Cryptosporidium to express both MHCI-
and MHCII-restricted model antigens. This allows for the first-time identification of parasite-
specific T cells within the gut, facilitating the study of T cell priming and trafficking. Using this
system, I have found that cDC1s induce gut-homing integrins on T cells during Cryptosporidium
infection. In addition, I have found evidence for changes in mLN DC ability to induce the
canonical gut-homing integrin LPAM-1(⍺4β7) during infection compared to homeostasis, pointing
to an infection-induced gene expression program in these DC, possibly related to their ability to
produce retinoic acid. However, when LPAM-1 is blocked, mice still control infection at
unchanged kinetics, indicating LPAM-1-independent mechanisms of T cell trafficking. Based on
my preliminary data, I will investigate the effect of Cryptosporidium infection on dendritic cells in
the intestinal mucosa and will ascertain the role of the integrin LPAM-1 and other homing
molecules in resistance to Cryptosporidium. I will utilize a combination of novel transgenic
parasites, genetic mouse models, single-cell RNA sequencing, and high-dimensional flow
cytometry to address these aims. These studies will provide an opportunity to train in cross-
disciplinary approaches in parasitology and immunology to better understand how immunity to
infection in the gut is regulated. The studies proposed here will impact our fundamental
understanding of mucosal immunology and drive the development treatment and prevention for
an important source of childhood mortality.

Public health relevance
Project Narrative In the setting of enteric infection, T cells are instructed to migrate to the site of infection by signals they receive from dendritic cells during priming. Using a murine model of Cryptosporidium infection and in vitro T cell activation assays, I have found that gut-associated DCs, specifically cDC1s, induce the gut-homing integrin LPAM-1 (⍺4β7) on activated T cells through RA production. The proposed project will address whether infection enhances gut DC ability to produce RA and to what extent LPAM-1 expression is responsible for T cell trafficking to the intestine in Cryptosporidium infection.